Mechanisms of mitochondrial-ER communication during dietary and thermal induced stress

Project Summary/Abstract
Obesity is a pandemic affecting 40% of the population that increases the risk of serious metabolic diseases
including type 2 diabetes and severe forms of SARS-CoV2 infection. Obesity reduces insulin sensitivity and
dysregulates glucose homeostasis sustaining high blood glucose levels and the development of type 2 diabetes.
Activation of brown adipocytes (BAs) is a promising approach to treat obesity and associated diseases. Brown
adipocytes rely on an extensive network of mitochondria that increases energy expenditure and maintains
glucose homeostasis through glucose, amino acid, and fatty acid oxidation. During fat-induced stress,
mitochondrial-endoplasmic reticulum (ER) communication sustains cellular function in BAs. However, the
mechanisms by which mitochondrial-ER communication shapes cellular adaptation during obesity are poorly
understood. Therefore, studying these pathways will provide new therapeutical approaches to target obesity.
The main goal of this application is to study the mechanisms of mitochondrial-ER communication that ensure
mitochondrial function and cellular homeostasis during diet-induced stress. We have described that in BAs
mitochondrial-ER communication promotes thermogenesis during cold stimulation through the ER-resident
kinase PERK. To follow up this work, in Aim 1, the effects of long-term high fat diet (HFD) will be studied in
UCP1-Cre PERK-/- mice exposed to different dietary and bioenergetic conditions. Our preliminary information
suggests that PERK may be signaling to the chaperone PPID to control mitochondrial protein import. In Aim 2,
structural approaches using Cryogenic Electron Microscopy (CryoEM) will be used to explore the molecular
interactions that control and maintain mitochondrial functions in BAs including mitochondrial protein import,
focusing on PPID-dependent pathway, and cellular respiration during dietary and thermal stress. Finally, in Aim
3 the role of PPID in physiology and cellular functions will be studied in mice exposed to diet and thermal stress.
While Aims 1 and part of 2 will be completed during the training stage, part of Aim 2 and the entire Aim 3 will be
conducted during the independent phase of the award.
The extensive training in different fields proposed in this application including physiology and cellular and
structural biology will provide the tools to become an independent researcher and study the mechanisms of inter-
organalle communication that regulate mitochondrial biogenesis and cellular metabolism. This training will be
received in the vibrant scientific communities of Dana-Farber Cancer Institute and Harvard Medical School. This
environment will expose me to the collaborations and discussions necessary for career development and future
opportunities. Dr. Puigserver mentorship will be supportive to establish those connections and actively guide me
in talk and manuscript preparation, student mentorship, experimental design, and career development. Together,
the research and career development plans proposed in this application will strengthen my skills and
competitiveness to become an independent researcher at a major institution.

Public health relevance
Project Narrative Communication between the endoplasmic reticulum (ER) and mitochondria is essential to maintain glucose homeostasis and whole-body energy balance. However, our knowledge on the regulatory elements that control the crosstalk between these two organelles, especially the regulation of mammalian mitochondrial protein import machineries and cellular respiration by the ER in health and disease, is very limited. Therefore, the goal of this proposal is to define mitochondrial-ER signaling pathways that control cellular function and energy expenditure in brown adipocytes during diet and thermal stress.